Cancer Center Administration

CANCER CENTER ADMINISTRATION - ABSTRACT
Administration at the Karmanos Cancer Institute (KCI) provides support to the Cancer Center leadership,
Research Program and Shared Resource infrastructure, KCI membership, and staff by providing services aimed
at relieving the administrative burden associated with research. Administration contributes to the mission of the
Cancer Center by providing efficient management of resources, facilitating key internal and external scientific
meetings, strategic planning, and developing useful metrics to aid in the decision making of KCI senior
leadership. Mr. Evano Piasentin, Associate Center Director for Research Administration, leads an experienced
administrative team. Administration supports 135 scientific members across four research Programs and nine
Shared Resources (including one under development). Additionally, Administration manages extramural funding
of $63 million (annual direct costs), KCI’s annual research budget of $21 million, and coordinated internal pilot
funding of more than $2 million since the last renewal.
Notable achievements during the past funding period include a restructuring of the administrative office to
capitalize on the unique skills of staff and provide a more efficient and dynamic environment to meet the needs
of the Cancer Center. Additionally, Administration supported the planning, process, and development of a new
strategic plan through organization of strategic planning retreats convening stakeholders from various disciplines
across KCI. The strategic plan is centered on five priority areas: immunology and immunotherapy, cancer
metabolism and metabolomics, biology of cancer health disparities, addressing multilevel determinants of risk
and survivorship, and increasing interventional research to reduce disparities. Administration continues to
implement significant upgrades to the Research Administration Application (RAA©), a homegrown repository of
CCSG data for KCI. With respect to space management, Administration managed a relocation of basic science
laboratories from the outdated Prentis Cancer Research Building to the renovated Elliman Research Building.
Finally, Administration played a central role in the development of several large, multi-PI project grants leading
to the first-ever funded SPORE grant at KCI; The Michigan Prostate SPORE (P50CA186786).